Ryanodine Receptors as Therapeutic Targets to Prevent Doxorubicin-Induced Lymphatic Dysfunction

PROJECT SUMMARY/ABSTRACT
Lymphedema is a major complication after radiation and/or surgery for breast and gynecological cancers.
Advancements in surgical techniques mitigate the risk, but the incidence of lymphedema is still high, and there
are no approved medications to prevent or treat it. Doxorubicin (DOX) is a central chemotherapy drug for treating
breast and gynecological cancers, but it increases the risk of lymphedema by 3-fold. The mechanism by which
DOX contributes to chronic lymphedema is unknown, but we found that clinically relevant concentrations of DOX
acutely inhibit lymph vessel (LV) contractions and reduce lymph flow by activating ryanodine receptors (RYRs,
intracellular calcium channels) in lymph muscle cells (LMCs), resulting in tonic Ca2+ leak from the sarcoplasmic
reticulum (SR) and lymphostasis. Sustained high levels of cytosolic Ca2+ [Ca2+i] can promote lipid peroxidation
and cell death pathways, and the increase in intraluminal pressure produced by lymphostasis can damage LV
walls and valve leaflets, synergistically causing chronic lymphatic injury. It is unclear whether DOX activates
RYRs through a direct interaction or indirectly by mediating the oxidation of RYRs. Indeed, DOX elevates both
cytosolic and mitochondrial superoxide (O2•-), which could contribute to RYR oxidation (receptor opening) and
subsequent Ca2+ leak. It is also unknown which RYR subtype (RYR1, RYR2, RYR3) is activated by DOX in
LMCs; if known, it could serve as a potential therapeutic target to prevent DOX-induced lymphatic dysfunction.
We propose RYRs are novel therapeutic targets in LMCs to prevent DOX-induced lymphatic dysfunction and the
development of chronic lymphedema. We hypothesize that DOX generates O2•- to acutely oxidize and open
RYRs to increase [Ca2+i] in LMCs, inhibiting LV contractions and inducing lymphostasis and lymphatic injury, and
added surgical insult potentiates this effect. Accordingly, we will use our well-established rat model to evaluate
RYRs as therapeutic targets to prevent DOX-induced lymphatic dysfunction. Three aims will integrate techniques
in preclinical studies to explore this hypothesis and will rely on protein and functional analysis of isolated LVs,
use optical imaging to assess volumetric lymph flow in vivo in response to DOX and RYR blockade, and
investigate the utility of RYR blockers, as a potential therapeutics in a preclinical model of lymphatic
insufficiency. Aim 1 will determine whether DOX-induced RYR activation is mediated by O2•- in LMCs. Aim 2 will
define the role of RYR subtypes in DOX-induced Ca2+ leak in isolated LVs and in lymph flow in vivo. Aim 3 will
investigate the combined impact of DOX ± RYR blocker on lymphatic function, lipid peroxidation, and lymphatic
morphology in a preclinical rat model of lymphatic insufficiency. Thus, we plan to explore RYRs as novel
therapeutic targets to prevent DOX-related lymphedema and evaluate whether RYR blockers can be utilized as
anti-lymphedema agents.

Public health relevance
Project Narrative Doxorubicin is a chemotherapeutic drug commonly used in breast cancer but is associated with a major complication called lymphedema, which is debilitating to patients. Our project explores how doxorubicin directly inhibits contractions of lymph vessels, which remove fluid from tissues to prevent lymphedema. There are no known medications to alleviate DOX-related lymphedema; however, we have identified a potential new target for anti-lymphedema medications.